Modulation of MMPs gene expression and activity by the microbiome in caries

Project Summary/Abstract
Caries is a multifactorial disease that results from an imbalance between the microbiome and the host, leading
to demineralization and destruction of the dental hard tissues. The etiology of caries attributes lesion progres-
sion to diet- and pH-dependent processes. However, the specific mechanisms resulting in the degradation of
dentin are unclear and have been thought to be mediated exclusively by enzymes from bacteria. New evidence
is challenging this concept of advanced caries pathology by suggesting that host-derived enzymes, such as
matrix metalloproteases (MMPs) that become activated by changes in the pH, primarily drive the tissue break-
down. Recent data indicates that dentin destruction and the response of the dentin-pulp complex to bacteria
invasion in caries involve complex enzymatic machinery. Indeed, fundamental questions remain concerning
the regulatory mechanisms that drive MMP expression and activation and how these mechanisms are modu-
lated by bacterial infiltration as caries lesion advances. The parent award will address these issues by (a) filling
the gap in knowledge regarding the breadth of the contribution of specific MMPs to caries lesion progression,
(b) defining the role of odontoblast-produced and dentin-released MMPs in caries, and (c) determining how the
shift in the oral microbiome can modulate MMPs expression and/or activation as the lesion progresses. The
knowledge generated in the parent award will provide essential baseline information to facilitate the PI’s long-
term research goal, which is the development of new dental therapies based on the modulation of MMP activity
in caries to stimulate dentin and pulp repair. This new therapeutic approach will be based on selective inhibi-
tion of damaging endogenous mechanisms and promotion of repair mechanisms that would fundamentally
change the way dentin caries are managed and surgically treated. In addition, a comprehensive career devel-
opment plan integrates the research aims with the training activities to allow the PI to achieve the following
short-term goals: (1) to acquire advanced knowledge on dentin organic matrix composition and biochemical
properties in health and caries disease, (2) enhance experience with methodologies for the study of oral pro-
teins and microorganisms in caries, including genomics and proteomics, and (3) develop skills in leadership
and scientific communication including writing, oral presentations and mentorship. However, the progress of
the parent award was impacted by a critical life event, which delayed the research and career development
activities and impacted reaching some of the milestones planned mainly for years 2 and 3 of the parent award.
This administrative supplement will support the PI in continuing her career trajectory and returning to full
productivity. Achieving the outcomes proposed for the parent award will be essential for the PI to transition to
her next career level, sustain a robust research program, increase scientific productivity, and ultimately miti-
gate the impact of the critical life event in her career development.

Public health relevance
Project Narrative Dentin matrix metalloproteinases (MMPs) are considered key proteases for tissue breakdown that advance caries lesions, but the actual contribution of MMPs to disease progression and how their expression and activity are modulated are unclear. The K08 parent award will fill major gaps in understanding endogenous processes in caries progression and provide insights into interactions between the microbiome present at different stages of the disease with host responses that express and/or activate dentinal enzymes. This supplemental award aims to ensure the continuity of the proposed training and research goals, mainly related to dentin-pulp genomics and proteomics, OMICS approaches and techniques, bioinformatics, and scientific writing.